Administrative Core

ABSTRACT – ADMINISTRATIVE CORE
The highly integrated nature of the University of Michigan O'Brien Kidney Translational Resource Center
(MKTC) requires a robust and active Administrative Core, which will coordinate workflow, distribution of
resources and operations assessment of the Biomedical Research Cores and Resource Development Core.
The Core will continue to set goals and objectives for the Center's operation and conduct ongoing review of the
Center through consultation and survey of the core users, advice of NIDDK Advisory Committees and
interactions with other institutional NIDDK centers, external O'Brien National resource Centers consortium
through the Data Coordinating Center. In addition, the Administrative Core will organize, stimulate and
evaluate interactions of the Center with our researchers to ensure that the Biomedical Research Cores and
educational programs are providing optimal support. Maintaining a vibrant educational environment for kidney
research, especially in T1 translational research, continues to be a major goal and the core will implement the
effective Educational Enrichment Program including the Summer Students Research Program. The
Administrative Core will oversee the resource expenditures of the MKTC and be responsible for the reporting
to internal and external stakeholders and to the NIH. The Core, through the Core's Working Group, will
oversee all Cores, ensuring that expenditure of cost-share funds are properly allocated to support priority core
services. The Core will also ensure that agreements between the administrations of entities who have agreed
to co-funding will be properly executed and documented The Administration Core will maintain a Website for
investigators and the public use to interact and to promote MKTC activities. The core will continue to support
an Annual Educational Retreat for all research base investigators, to highlight translational research
approaches, review research progress and obtain feedback on Center services. Throughout all these
processes, the core will obtain quality assurance and improvement information from Research Base
investigators.